INTERACTIONS OF COBALT III COMPLEXES WITH DNA AND RNA

The development of new molecules that bind strongly and selectively to DNA and RNA expands the range of potential therapeutic agents. Ideal candidates for such molecules are small metal complexes due to their wide range of structures and reactivities. The architecture of these molecules can be tailored to address a specific type of interactions with nucleic acids. We propose to synthesize a set of simple cobalt (III) complexes with the potential to interact with nucleic acids and/or their components through covalent attachment to ligand sites on the nucleic acid. The interest in these compounds stems from some preliminary results which indicate that cobalt (III) pentaammineaquo, [Co(NH3)5(OH2)]3+, binds irreversibly to DNA oligomers possessing GpC sites. It is likely that a covalent bond from the cobalt center to N7 of guanine would form upon loss of water from the cobalt. We wish to investigate the generality of this reaction with a variety of analogues of the parent compound and to determine the types and specificities of their interactions with a variety of nucleic acids. The cobalt complexes would have the general formula of [Co(Am)x(L)y(X)z[n+, where the number of potential leaving groups (X) is 1 or 2 and ammine type ligands (Am) and pi-donor ligands (L) occupy the remaining coordination sites on the cobalt center. The ligand L is a critical feature in the design since its presence can greatly influence the kinetics of the dissociation of X. Upon preparation of a set of cobalt complexes, their interactions, first, with nucleosides and nucleotides, then with nucleic acids, will be thoroughly investigated. The issues addressed in these studies would be the determination of binding constants, types of interaction (e.g., electrostatic, hydrogen bonding, hydrophobic and/or covalent) and the specificities of interactions (e.g., sequence specificity, conformational specificity etc). The methods used for these determinations include spectrophotometric titrations, equilibrium dialysis, viscometric titrations and chemical or enzymatic footprinting. The long range goal of these preliminary studies is to determine the feasibility of these cobalt complexes for use as therapeutic agents. The advantages of these compounds as therapeutic agents arise from the ease and low cost of their preparations, the ability to fine tune the reaction kinetics of their DNA binding by tailoring their design parameters and their propensities for water solubility. Thus, these agents could be viable alternatives for commonly used agents such as cisplatin.